NIAID DCR OPERATIONAL TASK ORDERCOVID FUNDING SUPPORTS THE NIAID DCR COVID WEBSITE AND THE VARIANT TESTING SAVE PROGRAM FOR VARIANT TESTING.

The NIAID Division of Clinical Research (DCR) plays an integral role in facilitating the efficient and effective performance of NIAID research programs on both the domestic and the international level. This is accomplished through a multi-faceted approach to the provision and support of services vital to the research infrastructure that include oversight and management of intramural clinical research.